Antimony-119 for Targeted Radionuclide Therapy

Project Summary/Abstract
In 2017, cancer was the second leading cause of death in the USA [1], illustrating the dire need for innovative, effective
therapies. We propose to test the Meitner-Auger electron (MAE)-emitting radionuclide antimony-119 (119Sb) for cancer
targeted radionuclide therapy (TRT) by measuring cell killing efficacy, comparing against clinical standard, and quantifying
biodistriubtion and lethal dose delivery via in vivo and ex vivo experiments. TRT uses biological targeting vectors (signal
molecules, antibodies) tuned to cellular disease markers (receptors, overexpressed proteins) to deliver radionuclides that
emit short range, highly damaging radioactivity inside diseased cells. TRT holds curative potential, including metastatic
disease, and can mitigate current radiation therapy side effects. Radionuclides with b- (high energy electron) emissions, a
particle (helium nucleus) emissions, and low energy MAE emissions have been proposed for TRT application [2]. MAE-
emitting radionuclides provide high radiation dose delivery (an advantage over clinical standard b--emitters [3]), decay to
stable isotopes providing simple dose tracking (an advantage over a-emitters), and can be produced on small cyclotrons
networked across the world (an advantage over a-emitters which are very challenging to produce [4]). Many in silico
studies on MAE TRT promote 119Sb as an ideal TRT candidate [5–7] due to the highly localized energy deposition of its 23-
24 low energy MAEs [8], low x-ray emissions providing clean dose profile, and high cyclotron production yields. However,
the lack of developed production technology and bifunctional chelator scaffolds have prevented application of 119Sb. I
spent the first three years of my predoctoral training developing production of medical quality 119Sb, and we have reported
the first stable complexation of radioantimony with a bifunctional chelator – I am now uniquely positioned to explore its
biological application. We hypothesize that 119Sb TRT agents will kill cancer cells more effectively than the current clinical
TRT standard. We propose to conjugate our bifunctional chelator to a glutamate-urea-lysine moiety which binds prostate
specific membrane antigen (PSMA), a well-recognized prostate cancer disease marker, and characterize the 119Sb-trithiol-
PSMA radiopharmaceutical with HPLC, serum stability, lipophilicity, and apparent molar activity (AMA) measurements. To
prove retention of the PSMA vector’s targeting, binding affinity, internalization kinetics, and efflux kinetics assays will be
conducted. ATP cell viability assays will measure cell killing efficacy and a clonogenic assay will monitor hereditary effects.
Similar studies of 177Lu-PSMA-617 will compare our TRT agent with the clinical standard. We will also investigate the
mechanism of damage with fluorescence microscopy using g-H2AX to quantify double stranded DNA breaks. We will
measure the radioisotope imaging analogue 117Sb-trithiol-PSMA in vivo pharmacokinetics using region-of-interest analysis
of single photon emission computed tomography (SPECT) images, and activity measurements via gamma counting will
determine ex vivo biodistribution in xenografted cancer tumor mouse models, providing information about
radiopharmaceutical targeting, delivery, metabolism, and in vivo complex stability. The OLINDA calculation formulism will
estimate whole-body, tumor, and organ specific dosimetry of our 119Sb-trithiol-PSMA from in vivo data. This work will
thoroughly probe 119Sb’s TRT capability and afford me access to excellent predoctoral training.

Public health relevance
Project Narrative Metastatic staging of breast and prostate cancer decreases five-year patient survival rates from 99% to 27% and 30% respectively [9] due in part to limited clinical treatment options—as current standard external beam radiation therapy plans (used in half of all patients cancer treatments [10]) for disseminated disease not only are unable to address this deficiency in treatment success but also deliver off-target dose and cause troubling side effects [11–14]. Targeted radionuclide therapy (TRT) using Meitner-Auger electron (MAE)-emitting radionuclides has curative disease potential as highly damaging, short range radiation dose can be targeted to cancer at the cellular scale, killing diseased cells while sparing healthy cells and mitigating radiation side effects. We propose to explore TRT potential of the MAE-emitting radionuclide antimony-119 by measuring its cell killing efficacy, comparing against clinical standard, and measuring in vivo biological distribution to quantify radiation dose delivery.